2024 Cell Polarity Signaling Gordon Research Conference and Gordon Research Seminar

Abstract
Initiated in 2014, the Gordon Research Conference (GRC) on Cell Polarity Signaling filled a very important but
unmet need, as there were no regular conferences on the broad topic of cell polarity prior to the initiation of this
GRC meeting. Based on highly positive feedback from the first four GRCs, we are organizing a fifth meeting for
2024 to continue an ongoing forum for the very dynamic and diverse cell polarity field. Polarity is fundamental
to all of biology, with profound implications for cell and tissue organization in normal development and
homeostasis, and in numerous diseases including cancer. For these reasons, cell polarity has become an
important area of research with increasing number of investigators. To bring new participants and topics to the
meeting, the 2024 GRC intends to diversify the topics even more under the subtitle of ‘Polarity and asymmetry
in tissue architecture and cell fate’, covering a new aspect of cell polarity that had not been covered previously.
A Gordon Research Seminar (GRS), organized by two postdoctoral trainees and subtitled “Mechanics of
polarity signal integration across scales” will precede the GRC. The GRS is expected to attract ~50 trainees to
present and discuss their research. The GRS will foster networking and collaborations to help trainees develop
their careers. It will also provide a valuable learning experience for those involved in organizing the GRS.
Several senior investigators in the cell polarity field will be invited to the GRS to discuss their research and
provide mentoring and feedback.
Sessions at the GRS and GRC will range from basic cell biology and development of model organisms to
translational studies in cancer biology. Many talks at the GRC will focus on the meeting subtitle – ‘Polarity and
asymmetry in tissue architecture and cell fate.’ The invited speakers for 2024 will be different from that of the
2022 conference, and the majority of them have never been invited as speakers to any previous Cell Polarity
GRC. Newly added topics and experimental systems will keep the meeting fresh and relevant and will broaden
the number of investigators who can present their research. Among the ~30 invited speakers/chairs from
multiple countries, 50% are women, ~30% are junior PIs. We paid special attention to diversifying demography
as well, although we not have exact data on the number of NIH-defined URM. 20 short talks will be selected
from submitted abstracts. Interactive poster presentations will take place on 4 afternoons, and several poster
presenters will be selected to present poster preview talks to advertise their poster. The program includes a
‘Power Hour’ to discuss the challenges women and URMs face in academia. We will promote diversity in the
programs for the GRC and GRS, through GRC minority fellowship funding, and through focused advertising via
scientific societies. We envision that the 2024 GRC/GRS will facilitate discussion of cutting edge research in
cell polarity and will foster collaborations that will fuel the field forward.

Public health relevance
Summary Cell polarity is of fundamental importance to all of biology and to human health and is perturbed in numerous developmental diseases and in cancer. Polarity provides a mechanism by which cells produce different types of cells, a critical process for stem cells to maintain tissue homeostasis and for multicellular organisms to develop their complex tissues and organs. This application aims to support a Gordon Research Conference and Research Seminar, which will bring together investigators and students working in this exciting field to share ideas, and to encourage cross-fertilization between basic discovery science and translational research.